ELECTROPHORETIC GERMINAL MUTATION TEST DEVELOPMENT

This contract on the mouse electrophoretic germinal mutation assay is an integral part of the Cellular and Genetic Toxicology Branch's program in mammalian germ cell mutagenesis testing.